The Effects Of Telemedicine on Health Outcomes, Costs, and Perceptions of Care Delivery in In-Center Hemodialysis

Approximately 750,000 adults in the United States (US) have end-stage kidney disease (ESKD), where they
require either dialysis or a kidney transplant in order to survive. Although in-center hemodialysis (HD) is the
most common treatment for ESKD, it is associated with extremely high costs and poor health outcomes.
Advances in communications technologies, combined with broad access to these technologies, have led many
US policymakers and healthcare providers to champion telehealth as a way to improve access to care and to
reduce costs in various healthcare settings, including the monitoring and treatment of patients with chronic
disease. Until recently, regulatory barriers have effectively prohibited physicians from using telemedicine to
deliver in-center HD care. This changed in March 2020, when emergency waivers issued in response to the
COVID-19 pandemic allowed nephrology practitioners (nephrologists and advanced practitioner providers
(APPs)) to deliver up to 4 encounters per month to HD patients via telemedicine. In the context of existing care
gaps and inefficiencies associated with the current system of physician reimbursement for dialysis care, there
are several ways in which telemedicine might improve dialysis care. Medicare’s 3-tiered monthly capitated
payment (MCP) system of reimbursing physicians for in-center HD care encourages nephrologists to see
patients up to 4 times per month, often with little or no benefits resulting from frequent visits. Paradoxically,
patients most likely to benefit from closer nephrology supervision (such as those recently discharged from the
hospital) are, on average, less likely to be seen frequently. By reducing the amount of time nephrologists
spend traveling to dialysis facilities to see patients frequently, telehealth could make it easier for practitioners to
align their rounding schedules with the needs of their patients and could reduce costs associated with time
spent traveling. Alternatively, if telehealth is used to replace interactions that are better conducted face-to-face
(such as vascular access examinations or dry weight assessments) or to see patients frequently who don’t
require closer supervision, then the adoption of telehealth could impair health and increase costs. We propose
3 specific aims that will leverage the recent increase in the use of telehealth following the COVID-19 outbreak
in order to assess the uptake of telemedicine for in-center maintenance HD care, to understand whether the
use of telehealth for in-center HD practitioner care affects healthcare costs and patient health outcomes, and to
describe patient and provider perspectives on telehealth in in-center HD. We propose a mixed-methods
approach that includes secondary analyses of several large administrative dialysis databases which we will
complement with semi-structured interviews of nephrology practitioners. When the current emergency waivers
granting broad access to telehealth end, policy makers and the clinical community will need to determine the
future role of telemedicine for in-center HD care. Our findings will inform these decisions by providing crucial
information about the benefits and potential dangers of telemedicine in this setting.

Public health relevance
Project Narrative Because patients who receive in-center hemodialysis for the treatment of end-stage kidney disease incur high costs and experience poor health outcomes (e.g. high mortality and frequent hospitalizations), it is important to find ways to improve care delivery. Advances in communications technologies have created numerous opportunities for telemedicine to improve chronic disease management and could help to address existing gaps and inefficiencies in the way that nephrologists deliver care to patients receiving in-center hemodialysis. In a combination of administrative data analyses and in-person interviews, we will exploit rapid increases in the use of telemedicine that have recently occurred in the setting of the COVID-19 pandemic to identify potential effects of telemedicine on healthcare costs, health outcomes, and patient and provider experiences in dialysis care.